Defining the developmental mechanisms of pericardium formation

PROJECT SUMMARY
The pericardium is a mesothelial sac that encapsulates the heart to support its development and maintain
cardiac homeostasis over time. Throughout the process of heart looping, the pericardium serves as a cell source
to form various cardiac structures, making it a crucial player in heart morphogenesis. However, little is known
about its developmental origins and how it acquires its unique properties in cardiac development, homeostasis,
and regeneration post-injury. While early mesothelial origins overall have only been recently described in detail
using the zebrafish, the pericardium has been particularly difficult to study due to its dynamic development and
a lack of genetic markers. Our lab has mapped mesothelial progenitors to the lateral plate mesoderm expressing
the transcription factor Hand2, and further linked Hand2 function to mesothelium and pericardium formation.
These conceptual and technical advances in mesothelial biology enable us to investigate how pericardial and
cardiac structures come together to form a single functional organ system during development. My expansion of
this data suggests that pericardial and cardiac progenitors are distinct progenitor populations that later come
together to fuse together during embryogenesis. The objective of this proposal is to uncover the developmental
mechanisms governing progenitor patterning into the heart and pericardium and identify the role of canonical
Wnt signaling that controls the pericardial emergence. In Aim 1, I will use a combination of transgenic zebrafish
lines that label the developing heart and pericardium, in vivo time-lapse imaging, stable genetic knockdowns of
cardiac components, and multi-color lineage tracing reporters to examine the cellular origins and dynamics of
the developing pericardium. In Aim 2, I will investigate the interplay between Hand2 and canonical Wnt signaling
by documenting the expression dynamics of Wnt targets in Hand2 mutant zebrafish, overexpressing Wnt
components, and using CRISPR-Cas9 mutagenesis to mutate Hand2 binding sites. Together, this project will be
the first to fully characterize how pericardial development proceeds and incorporates the heart and the interplay
between Hand2 and canonical Wnt signaling in controlling pericardium development.

Public health relevance
PROJECT NARRATIVE The pericardium is the mesothelial sac that surrounds the heart and is essential to support its development, maintain cardiac homeostasis over time, and respond to cardiac injury and infection. However, the developmental origins of pericardial development, and the cellular and molecular mechanisms involved in determining cell fate decisions between the pericardium and other parts of the cardiovascular system remain unknown. This will be the focus of my investigations, and the results from this work will expand our understanding of cardiogenesis and provide a framework to study the homeostatic functions of the pericardium.